Mitigation of GI-ARS by Lactobacillus species

Public radiation exposure due to large-scale radiation incidents is a rising global concern. Gastrointestinal
Acute Radiation Syndrome (GI-ARS) is associated with high morbidity and mortality. However, FDA-
approved therapeutics for GI-ARS are unavailable. Therefore, outlining the mechanisms of radiation injury to
develop targeted medical countermeasures (MCMs) is a high priority. The gut microbiome is highly
susceptible to ionizing radiation, and an altered microbiome is a major contributing factor in the pathogenesis
of GI-ARS. The gap in this field is that the precise mechanisms by which radiation causes dysbiosis of gut
microbiota and its impact on radiation injury are poorly defined. The long-term goal of our research is to
identify the radiation-sensitive microbiota in the gut and develop gut microbiome-targeted MCMs to mitigate
radiation injury. Our preliminary studies have identified that: 1) Lactobacillus casei and plantarum mitigate
radiation-induced epithelial tight junction (TJ) disruption and barrier dysfunction by distinct cellular
mechanisms. 2) Depletion of Paneth cell α-defensins plays a pivotal role in the mechanism of radiation-
induced microbiota dysbiosis. 3) When administered in diet 24 hours after irradiation, L. casei and L. plantarum
mitigate radiation-induced α-defensin depletion, microbiota dysbiosis, gut barrier dysfunction, endotoxemia,
and systemic inflammation. These findings form the scientific premise and support the central hypothesis that
“L. casei and L. plantarum synergistically mitigate GI-ARS by reversing dysbiosis of gut microbiota and
epithelial barrier dysfunction, leading to attenuation of endotoxemia and systemic inflammation.” We
will test this hypothesis by determining that 1) L. plantarum mitigates radiation-induced epithelial TJ disruption
by EGFR-mediated inhibition of c-Jun N-terminal kinase-2 (JNK2)/c-Src/protein tyrosine phosphorylation, 2) L.
casei mitigates radiation-induced remodeling of the actin cytoskeleton and mucosal barrier dysfunction in the
intestinal epithelium by a PKC-dependent mechanism, 3) L. casei and L. plantarum synergistically mitigate
radiation-induced intestinal barrier dysfunction, 4) Radiation downregulates intestinal Paneth cell α-defensins
by HDAC3-mediated histone deacetylation, 5) HDAC3 and α-defensin downregulation play crucial roles in
radiation-induced dysbiosis of gut microbiota, 6) L. casei and L. plantarum, and their 3KDF fractions mitigate
radiation-induced HDAC3 expression, α-defensin depletion, and gut microbiota dysbiosis, 7) Identifying the
lowest effective doses of L. casei, L. plantarum, and 3KDF fractions for mitigating GI-ARS, 8) Determining the
ideal time window for the effectiveness of L. casei, L. plantarum, and 3KDF fractions, and 9) Determining the
most effective doses of L. casei and L. plantarum, and the ideal time window for increasing the survival rate
after lethal dose irradiation. Completing this project will establish a significant causative relation of intestinal
Lactobacillus depletion with radiation injury. Furthermore, these studies will validate Lactobacillus-based
probiotic therapy as a novel microbiome-targeted MCM for GI-ARS under the Animal-Rule guidance.

Public health relevance
Public exposure to radiation by large-scale radiation incidents is a rising global concern, but there are no FDA-approved therapeutics for radiation injury. Therefore, we propose to conduct studies to uncover the cellular and molecular mechanisms involved in Lactobacillus-mediated mitigation of radiation injury. The outcome of these studies will identify a new medical countermeasure to treat radiation injury by targeting the gut microbiota.